IND-enabling studies for cell therapy in Parkinson's disease

Parkinson’s disease (PD) is a progressive neurodegenerative disease that is currently incurable with significant
unmet medical needs. In the US, over a million people suffer from this disease with an estimated cost of $27
billion per year. The mainstay of PD management is symptomatic treatment with drugs that increase dopamine
in the striatum. However, the utility of these drugs is significantly curtailed by waning efficacy and debilitating
side effects. Since PD stems from the degeneration of a single cell type, dopaminergic (DA) neurons that
supply dopamine to a defined location the striatum, PD patients have been viewed as optimal candidate for cell
transplantation therapy. Preclinical and clinical studies have demonstrated that transplantation of primary fetal
midbrain DA neurons into the striatum, provide significant and sustained restoration of function. However
ethical, practical and safety issues with using fetal aborted tissue and the recent progress in induced
pluripotent stem cells (iPSCs), grafting trials in PD are beginning to re-emerge world-wide with a new focus on
pluripotent stem cell technologies. However, clinical studies to date suggest that critical refinements in the
cellular product, in the delivery method, and in the clinical protocol by considering the incorporation of
adjunctive therapies, are essential to realize the potential of cell therapy in PD. NeoNeuron LLC has developed
intellectual property on scalable and effective technologies for generating an unlimited supply of DA neurons
from iPSCs and an image-guided methodology for delivering the cells into the target area of the brain enabling
functional recovery in the rat and in the nonhuman primate models of PD. In preparation for our Investigational
New Drug (IND) submission, NeoNeuron met with the U.S. Food and Drug Administration (FDA) and received
recommendations to conduct optimal dose range for the cellular product, iPSC-DA neurons, in the
immunocompromised rat model of PD. The company has established standard operating procedures to
expand this product under current good manufacturing practice (cGMP), and to produce DA neurons that will
be available as an off-the-shelf product. This feature is desirable for the development of the intended product
for clinical use and for commercialization. In Aim 1 we will show evidence of dose-response and adequate
levels of DA cell engraftment and survival for a 6-month duration in the hemi- parkinsonian rat model of PD.
Aim 2 will assess the impact of adjunctive physical and cognitive training on motor and cognitive functions in
the grafted animals. We will leverage single cell spatial transcriptomics profiling of the grafted cells to gain
insights into the mechanisms of actions of our product and of the adjunctive training intervention in enhancing
functional recovery. This Phase 1 will enable us to respond to the FDA recommendations by identifying the
optimal dose level of iPSC-DA cell engraftment and durable effects in the PD model and to proceed with our
planned Phase II SBIR proposal to establish the chemistry, manufacturing and controls, additional safety
toxicology studies and device testing in nonhuman primates for the IND filing.

Public health relevance
Project Narrative: Parkinson’s disease (PD) is a progressive neurodegenerative disease that is currently incurable and with significant unmet medical needs. In this application NeoNeuron LLC proposes to conduct U.S. Food and Drug Administration (FDA) requested IND-enabling studies to develop promising cell therapy approach for PD. NeoNeuron met with the FDA and received comments and recommendations to determine the optimal dose level range for the intended cellular product, DA neurons, in an immunocompromised rat model of PD. The proposed study is designed to demonstrate levels of DA neuron engraftment and survival for a 6-month duration and robust evidence of the durable effects of the intended product in vivo.